Mechanisms underlying the development, evolution, and function of human-specific cortical dopaminergic interneurons

PROJECT SUMMARY/ABSTRACT
Dopamine is a monoamine neuromodulator that is critical for the regulation of complex behaviors in the
human brain. Dysregulation of dopaminergic neurotransmission has been implicated in a spectrum of
psychiatric disorders, including attention deficit hyperactivity disorder (ADHD), bipolar disorder, and
schizophrenia. Moreover, a substantial proportion of psychotropic medications, most notably antipsychotics,
exert their therapeutic effects through the modulation of dopamine signaling. Elucidating the molecular,
cellular, and physiological underpinnings of the human dopaminergic system will be essential in the
development of novel and targeted therapeutic interventions for psychiatric illnesses.
Recently, our lab has uncovered a population of inhibitory interneurons in the cerebral cortex that
although present in non-human primate species, display unique molecular features in humans. We found
that in humans, but not other mammalian species, these interneurons express the key components of
dopamine synthesis and are capable of producing and releasing dopamine. Importantly, we identified that
dopaminergic interneurons are completely absent from the cerebral cortices of our closest living relatives,
the nonhuman African great apes (chimpanzee, bonobo, and gorilla species). These observed differences
in the abundance of dopaminergic interneurons between species, along with their distinct molecular profile
in the human cortex, suggests a human-specific role for these neurons within neocortical circuits. However,
fundamental questions on the development and function of these interneurons remain unanswered.
The objective of this proposal is to unravel the functional properties of human cortical
dopaminergic interneurons and to identify the developmental and evolutionary mechanisms
underlying the selective absence of dopaminergic interneurons in the cerebral cortices of nonhuman
African great apes. To accomplish this, we will use human and chimpanzee stem cell-derived brain
organoids to model developmental dynamics of brain development and assess the function of dopaminergic
interneurons with simultaneous profiling of electrophysiology and transcriptomics in single cells (Patch-seq).
The proposed experiments stand to significantly deepen our mechanistic and physiological understanding
of a highly-derived neuronal subtype in the human cerebral cortex. Unraveling the function of cortical
dopaminergic interneurons as well as the developmental and evolutionary mechanisms that underlie these
functions will provide crucial insights into the human dopaminergic system and identify putative targets for
intervention in dopamine-associated psychopathologies. In addition to this research, my training with the
University of Wisconsin Medical Scientist Training Program will provide an exceptional foundation in the
technical skills, responsible conduct of research, leadership, and clinical expertise to become a successful
independent physician-scientist in Child and Adolescent Psychiatry.

Public health relevance
PROJECT NARRATIVE Dopamine is a brain neuromodulator that contributes to higher-order brain functions and is critically involved in a wide range of psychiatric disorders, most notably schizophrenia. This proposal will unravel the physiology and function of a human-specific dopaminergic interneuron in the cerebral cortex along with an investigation of the evolutionary mechanisms that underlie these functions. The knowledge gained from these experiments will impart a refined understanding of the human dopaminergic system, provide potential therapeutic targets for dopamine-associated psychopathologies, and better position researchers and clinicians to tackle the increasingly heavy burden of psychiatric illness.